Perinatal Methylmercury Targets Hippocampal Stem Cells, and Reduces Neurogenesis

DESCRIPTION (provided by applicant): Methylmercury (MeHg) is a widespread and persistent environmental factor that adversely affects the developing brain, which is far more sensitive than the adult organ. From previous poisonings, we know that exposure of the developing fetus in the mother to MeHg can cause severe consequences, from mental retardation to seizures and malformations, many times without harming the mother. However, there are concerns that more subtle exposures may harm the developing brain, altering learning and memory, for which the hippocampus is critical. In previous work, we found that exposing postnatal rats to moderate levels of MeHg rapidly impaired production of neurons and later produced deficiencies in hippocampal structure and function. We have now discovered that hippocampal neural stem cells, that produce neurons and glia, are exquisitely sensitive to MeHg, which causes them to die within hours. We now plan to define the lowest levels of MeHg that can cause stem cell death, and define its relationship to later loss of neurons and memory functions. In Aim 1 we will define how little MeHg in newborn rats can cause stem cell death, and identify which of several stem cell types are affected. Subsequently, 2 weeks later, we will count total number and types of neurons and glia to see whether killing precursors leads to later losses of specific populations of hippocampal cells, as we see with higher exposures. In Aim 2, we will determine whether lower exposures and losses of cells can impact learning and memory of the animals at 4 weeks of age. When complete, these studies will identify a new, highly sensitive target of MeHg, hippocampal stem cells, and will establish a novel model system. By focusing on the stem cells, rather than simply the whole brain organ as is frequently done, we may detect toxic effects of environmental factors that are otherwise missed. Or we may find that levels of known factors, like MeHg, thought to be safe, may actually have previously unrecognized harmful effects. This model system offers the possibility of defining the temporal sequence of molecular and cellular events that lead to subtle structural and functional changes in the brain during a critical window of developmental vulnerability. This information may shed light on the ways environmental exposures can impair learning and memory.

Public health relevance
PUBLIC HEALTH RELEVANCE: These studies will identify a new and highly sensitive target injured by environmental factors, the hippocampal stem cells, involved in learning and memory. In turn, the new cell-based strategy we have developed may be used to examine the effects of a variety of other factors currently considered safe. These studies will identify a new and highly sensitive target injured by environmental factors, the hippocampal stem cells, involved in learning and memory. In turn, the new cell-based strategy we have developed may be used to examine the effects of a variety of other factors currently considered safe. __SpecificAimsTextDelimiter__ Hypothesis: We hypothesize that stem cells in developing hippocampus are particularly sensitive to teratogenic effects of MeHg, and that perinatal exposure will lead to precursor apoptosis, reduced neurogenesis and deficits in learning and memory. MeHg is a widespread and persistent neurotoxicant that adversely affects the developing brain, which is far more sensitive than the adult organ. While historic poisonings in Minamata Bay and Iraq defined severe neurodevelopmental consequences ranging from mental retardation and cerebral palsy to seizures and malformations, concerns about more subtle exposures remain, especially regarding learning and memory. In previous studies, we focused on a structure critical for learning and memory, the hippocampus, and found postnatal MeHg (5μg/gm) exposure impaired developmental neurogenesis and produced subsequent structural and behavioral deficits. More importantly, we discovered that hippocampal neural stem cells are exquisitely sensitive MeHg targets. We are now applying for the R21 mechanism because of its goal of encouraging design of novel experimental systems that identify new targets. Significantly, we propose to use exposures (0.2-0.6μg/gm) that are 10-15-fold lower than those used classically by Rodier (5μg/gm) and that approximate single daily exposure used by Newland in the 9-week chronic exposure model that produces abnormal adult behavior. If substantiated, this approach would define cell type-specific sensitivity to MeHg that goes undetected when using whole brain or regional biochemical/genetic approaches. In turn, the hippocampal stem cell would represent an important and highly sensitive cellular target in which to assess neurotoxicants and define underlying molecular mechanisms. This information may shed light on loci at which developmental teratogens impair learning and memory. We explore MeHg effects on hippocampal development and function in two Aims: Aim1: Define the early effects of MeHg exposure on postnatal day 7 (P7) rat hippocampal neural stem cells and later production of neurons and glia at P21. Preliminary data indicates that exposure of P7 rats to a single injection of 0.2-0.6μg/gm MeHg increases apoptosis of hippocampal dentate gyrus neural stem cells. We now plan to define exposure-response relationships of MeHg (0.1-10μg/gm) to apoptosis (activated caspase 3) and precursor mitosis (BrdU labeling), and relate changes to distinct neural stem cell populations identified by nestin, SOX2 and GFAP labeling. Further, as losses in proliferative stem cells may lead to reduced cell generation, we will quantify neuronal and glial absolute cell numbers at P21 by employing unbiased stereology, with preliminary data suggesting neuron-specific losses. Aim 2: Characterize effects of P7 MeHg exposure on juvenile hippocampal-dependent spatial learning and memory at P35. An early toxic insult may have later behavioral consequences. Preliminary data in one experiment (2 litters, 11 animals/group) suggests MeHg (0.6μg/gm) exposed juveniles are able to acquire spatial learning in a Morris water maze task but fail to exhibit 2 day or 2 week recall, a deficit in memory. These studies will be repeated to increase sample sizes and achieve independent experimental replication. Should they be supported, additional hippocampal-dependent learning tasks will be considered. These studies will identify a new, highly sensitive toxicant target, hippocampal dentate gyrus stem cells, and will establish a novel model system. The strategy of focusing on hippocampal stem cells may allow detection of neurotoxicant effects that go unrecognized when using whole brain or regional biochemical and genetic approaches. While contrasting substantially with current chronic exposure paradigms, this model system offers the potential to define the temporal sequence of molecular and cellular events that lead to subtle structural and functional changes in brain development during a critical window of vulnerability.